Improving alcohol and substance use care access and outcomes during the reproductive years: A Type 1 Hybrid Trial in Family Planning Clinics

Rates of risky alcohol and drug use and alcohol and substance use disorders
(AUDs/SUDs) are highest among young adult women compared to other periods of the
life course. AUDs and SUDs are associated with significant and lifelong behavioral,
mental, physical, and other health consequences for women. There is an urgent need for
innovative methods to address alcohol and substance use in preventive healthcare
settings. Women’s health clinics are uniquely well-suited, but entirely understudied,
contexts for implementing and scaling integrated alcohol/drug use services. While
screening, brief intervention, and referral to treatment (SBIRT) is a widely accepted,
evidence-based intervention for alcohol use in primary care and mental health settings,
little is known about the facilitators and barriers to the uptake and sustainment of SBIRT
in these clinics. Even less is understood about telemedicine, which has been rapidly
rolled out as a SBIRT delivery platform. Further, virtually no evidence exists on effective
organizational level implementation strategies to accelerate SBIRT’s adoption in
women’s health settings.
We propose an explanatory, sequential, mixed methods study to evaluate SBIRT in an
expansive clinic network of a national women’s health organization – a novel and highly
impactful setting that reaches women at greatest risk for AUDs/SUDs. Our integrated
study draws upon the evidence-based implementation approach, Implementation and
Sustainment Facilitation (ISF), guided by the Consolidated Framework for
Implementation Research and Reach, Effectiveness, Adoption, Implementation and
Maintenance models. In Aim 1, to identify specific targets for implementation,
sustainment, and scale-up of SBIRT, we will conduct administrative surveys with clinic
stakeholders (clinic directors, providers, and staff n=153) and key informant interviews
with stakeholders and patients (n=40) to investigate organizational practices and
perspectives on alcohol- and substance-related services. In Aim 2, we will conduct a
dual randomized Type 1 Hybrid Effectiveness-Implementation trial testing SBIRT (inperson
and telemedicine) vs. usual care, within a large, high-volume Northeastern
affiliate of the national organization. We will randomize 400 patients across 4 clinics,
collecting patient level data on alcohol and substance use primary effectiveness
outcomes, as well as secondary mental/physical health, quality of life, and wellbeing
outcomes at baseline, 30 days, and 3 months. Aim 3 will explore facilitators and barriers
to SBIRT adoption and the ISF implementation strategy via surveys and interviews with
clinic directors, providers, and staff (n=20) and patients (n=20) electronic medical
records. Results will provide new, timely evidence to inform scale-up of alcohol and
substance related services in women’s healthcare settings nationally.

Public health relevance
Alcohol and other substance use disorders in women are of great public health relevance given their association with significant and lifelong adverse physical, mental, and other health consequences. This implementation trial will evaluate health clinics as a novel setting in which to simultaneously test the effectiveness of screening, brief intervention, and referral to treatment (SBIRT) for alcohol and drug use. Coupled with an evidence-based Implementation and Sustainment Facilitation implementation strategy, our findings will ultimately support adoption and scale-up of substance-related care across a premier national healthcare organization and its expansive network of clinics serving millions of women in the U.S. every year.